Computational methods for discovery of disease-modulating microbial genes

ABSTRACT
Microbial genes in gut and diseased tissues were recently linked with progression and outcomes of different
human diseases, including cancer and immune diseases. Deciphering the pathogenic roles of different microbial
genes can improve diagnosis, prognostication, and treatment of human diseases. Yet, current methods for RNA
and shotgun metagenomic sequencing focus on microbial species, and do not allow a systematic detection or
quantification of microbial genes. Therefore, current methods for disease prognostication and biomarker
discovery are unable to consider microbial genes that influence human diseases. Our overarching hypothesis is
that there are unknown associations between human diseases and the microbial genes in diseased tissues and
in the gut. Our long-term goal is to unravel these associations using novel computational approaches that will
allow detection and quantification of microbial genes in diseases. In Aim 1 we will develop methods that harness
RNA sequencing to detect microbial gene expression in diseased tissues. This will allow microbial biomarker
discovery and provide a comprehensive database of the microbial genes that are expressed in various human
tissues and conditions. In Aim 2 we will develop methods to quantify gut microbial gene capacity in human
diseases. This will allow identification of gut microbial proteins, peptides, and domains that are important in
human diseases, to ultimately yield new diagnostic and treatment strategies based on gut microbiomes. Overall,
this project will provide innovative methods to allow detection and quantification of microbial genes from
abundantly used sequencing technologies. We will establish user friendly software and databases, allowing new
discoveries with existing sequencing platforms. We expect that the methods developed through this project will
be extensively adopted by the relevant research communities, improving our understanding of the roles of
microbes in human diseases and ultimately allowing the development of new disease detection and intervention
strategies based on microbial genes.

Public health relevance
Project Narrative Viruses and bacteria underlie different human diseases, imposing a major, continual health threat. We propose to develop novel computational methods to detect and quantify microbial genes in human diseases. These methods will unravel new roles of microbes in human diseases and can ultimately lead to biomarker discovery and development of new therapeutic strategies.